The contributions of neural control and mechanosensation to rehabilitation induced spine muscle recovery

PROJECT SUMMARY
Low back pain (LBP) is a complex condition that affects 65-85% of the population, and is the leading
musculoskeletal condition contributing to disability in the United States. Disc injury is the most common
injury and 75% of individuals undergoing surgical and rehabilitative interventions for this condition
experience suboptimal or poor outcomes. These patients demonstrate disability and deficits in functional
capacity, and paraspinal muscles in these individuals have been shown to be altered in volume,
composition, and mechanical properties. These maladaptive changes influence the ability for the muscle
to respond appropriately to rehabilitation efforts in a subgroup of individuals with chronic back pain who
do not demonstrate the expected acute activation responses to exercise. While the structural and
adaptive capacities of healthy muscle are well understood, pathological muscle recovery and activation
deficits are less clear and may be influenced by neurogenic and/or muscle specific impairments. To
address this gap in knowledge, the purpose of this proposal is to compare central and peripheral origins
of impaired activation in individuals with chronic disc injury who do, and do not respond to exercise. Our
central hypothesis is that individuals with non-responsive chronic disc injury will demonstrate a spectrum
of impairments in cortical activation, peripheral nerve physiology, and/or muscle dysfunction that
preclude normal responses to exercise. Aim 1 will use a novel functional MRI technique and
electromyographic measurements to compare responder and non-responder groups in patients with
chronic lumbar disc injury. Aim 2 will compare corticomotor excitability and intracortical inhibition and
facilitation between individuals who do and do not respond to exercise. Aim 3 will compare ex vivo
passive and active mechanical responses, and transcriptomics from intraoperative multifidus biopsies of
patients with chronic lumbar disc injury to evaluate muscle mechanotransduction. These experiments will
elucidate the neurogenic and muscle-specific contributions to muscle adaptation in the presence of
chronic lumbar spine pathology and pain. These contributions are significant because they are critical
steps in a precision medicine approach aimed at reversing maladaptive muscle changes that obstruct
patient recovery. The proposal is innovative because it combines novel direct tissue testing, cortical
assessments, and spine imaging methods to measure muscle structure, function, and adaptation in living
humans. We expect an immediate impact on rehabilitation because these findings will provide data and
methods for identifying patients who will, or will not, respond to standard rehabilitation programs. In the
long-term, we expect these experiments to provide direction for unique, patient-specific pharmacological,
surgical and rehabilitation programs.

Public health relevance
Project Narrative Low back pain (LBP) is a condition that affects a majority of the US population and is responsible for a significant proportion of health care costs and utilization. Lumbar spine muscle is compromised in LBP, and recent work from our previous grant identified individuals who do, and do not, respond to an exercise based physical therapy program based on measurements representing activation capacity of lumbar muscle. Here, we will characterize the neurological and muscle specific features that may contribute to limited activation in an attempt to identify sources of resistance to recovery in patients with chronic disc injury and identify precision rehabilitation approaches for this complex population of individuals.